PLA2G2D Antibodies for Cancer Immunotherapy

PROJECT SUMMARY / ABSTRACT
Currently approved immune checkpoint inhibitors (ICIs) have revolutionized cancer therapy. However, most
patients do not respond to these treatments because of primary or acquired resistance. Identifying new immune
regulators and developing therapeutics targeting such molecules is a current focus in immuno-oncology. We
have found that the secreted phospholipase A2 PLA2G2D is highly expressed in various human tumors and
positively correlated with that of classic checkpoints such as CTLA-4, PD-1, and PD-L1. PLA2G2D potently
diminishes dendritic cell function, suppresses T cell activity, and promotes macrophage M2 polarization.
Accordingly, studies using genetically-engineered loss- or gain-of-function mice demonstrate that PLA2G2D
strongly enhances tumor growth, indicating that PLA2G2D is a novel, targetable checkpoint for tumor
immunotherapy. We have generated more than 700 anti-PLA2G2D monoclonal antibodies, and using a series
of in vitro biochemical and immune cell functional assays we have identified 39 leading function-blocking
candidates. This proposal seeks to evaluate the anti-tumor efficacy of the 5 most functionally potent drug
candidates (which do not cross-react with mouse PLA2G2D), alone and in combination with existing ICIs, using
syngeneic tumor models in transgenic PLA2G2D-humanized mice. We will also assess how anti-PLA2G2D
changes the tumor immune profile and histologically evaluate PLA2G2D protein expression in various human
tumors using our drug candidate (Aim 1). The best drug candidate identified in Aim 1 will then be subjected to
non-GLP maximum tolerated dose toxicity and toxicokinetic evaluation in cynomolgus monkeys (Aim 2).
Collectively, the successful execution of this proposal will enable us to nominate our final lead molecule and
begin IND-enabling studies as part of a follow-up phase II SBIR proposal. Ultimately, an efficacious therapeutic
anti-PLA2G2D antibody will comprise a new treatment for patients resistant to currently available ICIs.

Public health relevance
PROJECT NARRATIVE The clinical success of immune checkpoint inhibitors (ICIs) represents a transformative advancement in cancer therapy, however >70% of patients fail to respond and new treatments promoting anti-tumor immunity are still urgently needed. PLA2G2D, a member of the secreted phospholipase A2 family, has emerged as an important negative immune regulator and a novel checkpoint suppressing anti-tumor immunity. This project seeks to identify the best anti-PLA2G2D monoclonal antibody drug candidate for development as a novel immunotherapy to benefit patients resistant to current ICIs.